Investigation of cerebello-thalamic circuits for the treatment of headache

There is a significant unmet need for new approaches to treat migraine and post-traumatic headache (PTH) in
Veterans who have suffered traumatic brain injury (TBI). The major aim of this proposal is to modulate
cerebello-thalamic circuits to treat migraine and PTH. Headache reduces quality of life and can coincide with
disabling sensory abnormalities including photophobia and pain. Migraine alone is estimated to affect 18% of
women and 6% of men (12% overall). However, this prevalence is even greater in Veterans (50% overall) who
have served in Iraq and Afghanistan and have experienced TBI and/or post-traumatic stress disorder. To date,
nearly half of patients who have either migraine or PTH receive no beneficial outcomes with current
treatments.
This proposal will test the hypothesis that inhibition of cerebello-thalamic circuits can be used to treat migraine-
like behaviors in mice. In the first aim, the plan is to inhibit the posterior thalamic area and the fastigial nucleus
of the cerebellum to treat mice that are in a headache-like state. To model headache, we will use calcitonin
gene-related peptide (CGRP) (a neuropeptide that is necessary and sufficient to induce migraine) and a TBI
model involving mild closed head impact. We will test mice in three translatable behavior paradigms that
measure light aversion, touch hypersensitivity and grimace. We will modulate the posterior thalamic area and
fastigial nuclei of the cerebellum using a chemogenetic strategy with an inhibitory ligand-activated designer
receptor. Our preliminary data indicate that stimulation of those two brain regions is sufficient to induce
migraine-like behaviors in mice. Successful completion of this aim will provide translatable targets for direct
brain modulation to treat headache disorders. In the second aim of this proposal, we will use blood-oxygen-
level-dependent functional magnetic resonance imaging (BOLD fMRI) to identify downstream targets of the
posterior thalamic area and cerebellum during a migraine-like or post-traumatic headache-like state. We will
perform imaging in mice after they are given CGRP, pituitary adenylate cyclase-activating polypeptide
(PACAP) (a peptide that is also reported to cause migraine in patients), or mild TBI. We will also
optogenetically stimulate the posterior thalamic area and cerebellum fastigial nucleus to map functional
connectivity changes of downstream targets in the brain. The goal is to identify additional brain targets that are
more accessible for modulation.
The significance of this study is the potential translation of these pre-clinical studies to the clinic. With large
populations of Veterans suffering from headache disorders the need for new therapeutics is critical. This study
has the potential to provide a road map for new therapeutic approachs to treating migraine and PTH.

Public health relevance
Migraine and post-traumatic headache are common chronic pain conditions that affect a disproportionately large number of Veterans. Only about half of patients will receive benefit from current treatments for these headache disorders. There is a critical need for better therapeutics and improved treatments. The goal of this study is to use brain modulation as a treatment of migraine and post-traumatic headache and develop refined brain activity maps. The approach will be to use brain modulation in mice during headache-like states to treat their headache-like behaviors. Functional imaging will be used to map downstream targets of brain regions for the development of brain-wide activity maps contributing to headache. These maps could be used for future brain stimulation studies in humans to treat headache. Veterans will directly benefit from the development of new treatments for migraine and post-traumatic headache.